Animal Structure and Function

ABSTRACT
Animal Structure and Function Core
The Animal Structure and Function Core provides centralized space for state-of-the-art structural and
functional animal testing with a dedicated animal care technician to conduct the testing and to train
investigators and their staff on the use of the new equipment. The number of faculty in the Department of
Ophthalmology conducting animal structure and functional testing has grown rapidly in recent years. With
this critical mass of investigators, there are compelling financial and logistical reasons to minimize the
number of animals in scientific studies. The use of ocular imaging methods that enable longitudinal
observations in a living animal can greatly reduce the need to sacrifice animals at different time points in an
experiment. It also provides invaluable information that is used to evaluate the accuracy of mouse models of
human eye diseases. In addition, the high cost of retinal imaging devices has made it prohibitively
expensive for individual scientist to purchase, therefore limiting the scope of their scientific investigations.
This core will provide a range of imaging and functioning testing services including the Micron IV Animal
Imaging System with multifocal ERG and ERG setup, Spectralis SDOCT system for spectral domain optical
coherence tomography studies and PacScan 300 A-scanner for measuring axial length, anterior chamber
depth and lens thickness, ultra sound imaging allowing our researchers to make most efficient use of their
time and resources.